A modular system for murine CRISPR genome and epigenome editing

Project Summary
RNA-guided DNA sequence recognition by CRISPR/Cas9 has been exploited to develop an array of
genome and epigenome editors, including base editors, primer editors, CRISPR-activators (CRISPR-a) and
CRISPR-interference (CRISPR-i). These editors consist of either nuclease dead (dCas9) or DNA-nickase
(nCas9) variants of Cas9 fused at N and C termini to “accessory protein” which contain the editor-specific
activity. The enzymatic activities of these accessory proteins are being evolved very rapidly to increase the
accuracy, efficiency, and types of editing possible. Mice harboring these editors as transgenes are invaluable
research tools. However, generating mice containing transgenes that express the latest suite of Cas9 editors is
challenging, given their rapid rate of change and ever-increasing number. These editors can be delivered using
adeno-associated virus (AAV) vectors, but due to packaging limits of AAV most require a dual AAV strategy
involving intein-mediated protein splicing, which hampers editing efficiency and homogeneity. Here we propose
to generate mouse lines that express the core dCas9 or nCas9 RNA-guided DNA sequence recognition
platforms, functionalized at N- and C-termini with protein ligation tags. The accessory proteins and guide RNAs
will be introduced using single AAV vectors. This combination will achieve higher level and more homogeneous
editing than possible with AAV-only strategies, while retaining flexibility and the ability to exploit the latest
advances in editor enzyme engineering. In Aim 1, we will create Cre-triggered mouse/AAV systems for
CRISPR-i/a. We will create mice with Cre-activated expression of dCas9 with N- and C-terminal protein ligation
tags, which will efficiently join to AAV-delivered N- or C-terminal epigenetic editors to implement CRISPR-i/a. In
Aim 2, we will create Cre-triggered mouse/AAV systems for base and prime editing. We will create mice with
Cre-activated expression of nCas9T (nicks the target strand) with N- and C-terminal protein ligation tags, which
will efficiently join to AAV-delivered N- or C-terminal base editors. We will further create mice with Cre-
activated expression of nCas9NT (nicks the non-target strand) with N- and C-terminal protein ligation tags,
which will efficiently join to AAV-delivered reverse transcriptase. These mouse/AAV systems will be invaluable
reagents to probe disease biology, perform proof-of-concept therapeutic gene editing, and enable efficient in
vivo CRISPR screens using genome or epigenome editing.
This proposal is responsive to PAR-21-167. Development of Animal Models and Related Biological
Materials for Research.

Public health relevance
Project Narrative Modifying the genome and the epigenome has become possible by engineering a protein known as Cas9. To maximize the usefulness of these technologies in mice, we will develop a modular system that efficiently expresses Cas9-based editors in vivo and at the same time allows components to be easily exchanged so that it keeps pace with the rapid development of new and improved editing tools.